Genome Characterization Unit

ABSTRACT: ADMINISTRATIVE CORE (AC)
The mission of the University of Southern California (USC) Center for Optimization of Participant Engagement
for Cancer Characterization (USC COPECC) is to provide both the biomedical and patient communities with
optimized best practices for Participant Engagement in genomic research, specifically in the context of Hispanic
patients diagnosed with Colorectal Cancer (CRC). USC COPECC will operate as an NCI U2C Participant
Engagement in Cancer Genome Sequencing (PE-CGS) Center, and will participate as a member of the NCI PE-
CGS Network. COPECC will be locally managed by the Administrative Core (AC), which will serve as the hub of
the Center's activities, including the management, coordination, supervision and promotion of the Center
activities. USC COPECC builds on the strong foundation of a significantly diverse and Hispanic enriched patient
population, established standard processes for Participant Engagement and recruitment into genomic studies,
highly experienced genome scientists with vast experience in clinical cancer genomics, and strong leadership in
the areas of oncology, genetic counseling, epidemiology, and behavioral science. The administrative leadership
will be primarily responsible for the Center's strategic planning, including: defining and upholding its mission and
objectives, conducting environmental scanning for strategy development, directing and managing strategy
implementation, and ensuring adjustments are made for continuous quality improvement (CQI) based on
program evaluation.